Innate immune signaling and stress response

ABSTRACT

Membraneless compartments play a vital role in maintaining cellular and organismal homeostasis by
modulating cell survival and cell death. Stress granules, and inflammasome-­induced specks are
membraneless compartments that provide contrasting cell fate choices to the cells – survival or pyroptosis
(programmed cell death) during physiological or virus induced cellular stress. NLRP3, a global sensor of
pathogen–associated molecular patterns (PAMPs) and danger–associated molecular patterns (DAMPs),
senses cellular perturbations in the cytosol to trigger the assembly of a large caspase-­1-­activating protein
complex termed the NLRP3 inflammasome. Autoproteolytic maturation of caspase-­1 due to NLRP3
inflammasome activation leads to pyroptosis, and maturation of pro-­inflammatory cytokines interleukin (IL)-­
1β and IL-­18. Despite the ability of NLRP3 to respond to diverse cues of cellular or virus induced stress,
mechanisms controlling the cross-­talk between inflammasomes and stress granules remain elusive. In our
quest to study this cross-­talk, we have identified DDX3X, a stress granule component, as an upstream
regulator of NLRP3 inflammasome to canonical and viral triggers. In this R01 renewal, we propose to identify
the molecular and cellular mechanisms of DDX3X-­mediated NLPR3 inflammasome activation and its
modulation by stress signals during inflammation and viral infections. Understanding the cross-­talk between
cellular stress response molecules and innate immune signaling will lead to novel therapeutic targets for
inflammatory and infectious diseases.

Public health relevance
RELEVANCE STATEMENT Stress granules and their components have been implicated in various biological processes related to human health including regulation of infectious, inflammatory, and neurodegenerative diseases. However, there is a major gap in the field regarding the intersection between innate immune response and stress response in multiple human diseases, including viral infections. Our proposal will uncover the mechanisms governing the cross- talk between stress response and host innate immune pathways that dictate protective or pathogenic host response which could be targeted therapeutically.